Adapting ECHO for Autistic Children's Communication

PROJECT SUMMARY/ABSTRACT
This K23 Award is essential to the Candidate's (Dr. Andrea Ford) success as an independent early childhood
special education community-engaged researcher. Dr. Ford's research mission is to partner with relevant and
interested parties to design and deliver feasible, acceptable, appropriate, and efficacious professional
development for preschool educators. In doing so, she aims to increase the adoption and use of neurodiverse
affirming, naturalistic developmental behavioral intervention strategies to promote positive communication
outcomes for autistic preschoolers. To achieve this goal genuinely and rigorously, Dr. Ford must gain
knowledge and hands-on experience in community-based participatory research methods, mixed methods
research, and executing randomized control trials in complex educational settings. Dr. Ford has assembled a
complementary team of NIH-funded experts with experience in community-engaged research, autism,
communication, dissemination, and implementation—Drs. Meinzen-Derr, Landa, and Rosen. Along with these
mentors, Dr. Ford crafted a career development plan to provide her with the necessary training and
experiences to elevate her research program to the next level. As outlined in the training plan, Dr. Ford's
career development plan is balanced with formal coursework, professional development experiences to apply
this knowledge, and regular mentoring and consultation meetings to coalesce knowledge and skills gained.
This training plan and research aims will build on her existing skill set in observational and measurement
research. Matched with the Career Development aims, the proposed K23 research project seeks to
unite preschool educators and researchers through an ongoing, virtual learning community, adapting
the Extension of Community Healthcare Outcomes (ECHO) Model from the medical field to education. There
are two aims: Aim 1 (Inform Development): we will probe the professional development needs, priorities, and
preferences of 75 preschool educators through Group Level Assessment methods. This methodology allows
for real-time analysis and employs preschool educators as co-analysts and equal partners in the research to
inform the development of the Preschool Autism ECHO; Aim 2 (Develop and Pilot Study): we will examine
the feasibility of the Preschool Autism ECHO through a mixed methods approach. Four content specialists and
35 preschool educators will participate in a collaborative virtual learning community. Data collection includes
educator self-report questionnaires, language and communication measures for autistic preschoolers, post-
session surveys, and qualitative interviews. The team hypothesizes that participation in the Preschool Autism
ECHO learning community will be feasible and result in positive changes in educators' knowledge, attitudes,
self-efficacy, and intention to implement the strategies. Dr. Ford's subsequent research will refine and optimize
the program, testing its impact on preschool educators' strategy use and autistic preschoolers' communication
outcomes. Her trajectory from to an Early Career R21 is strong and strengthened as a K23 mentee.

Public health relevance
PROJECT NARRATIVE This dissemination and implementation research identifies and addresses the professional development needs of preschool educators who support the communication of autistic preschoolers. We will create communities of practice using the Extension of Community Healthcare Outcomes (ECHO) Model—extending the model from a healthcare setting to an early education setting, where nearly 90,000 autistic preschoolers receive instruction in the US. The project presents an opportunity to increase the use of evidence-based communication strategies in classroom instruction and facilitate the uptake of research findings into educational practice.